Core A: Administrative Core

PROJECT SUMMARY – Core A (Administrative Core)
Yale TMC aims to map cellular senescence in primary (bone marrow and thymus) and secondary (tonsil and
lymph node) lymphoid organs, which requires assembling a highly multidisciplinary team with diverse expertise
to characterize and understand cellular senescence and associated environments in human tissues. The
Administrative Core is led by Drs. Fan and Halene, whose have a long-standing record of active collaboration,
extensive experience in NIH consortium activities, and the management of large team projects. A program
manager will coordinate all administrative activities within Yale TMC and the communications with NIH SenNet
program staff. Specifically, the Administrative Core will fulfill the following key functions: (1) establish a
leadership plan and the operation structure to supervise and manage all research activities, set up a decision-
making procedure for the TMC’s governance, establish supervisory mechanisms to ensure effective internal
management of ongoing research and participation in SenNet activities; (2) establish the TMC coordination
plan including communications and collaborations between the Cores within Yale TMC, define and monitor
specific responsibilities of each Core, manage the pilot grant projects, evaluate progress and milestones, and
develop strategies to minimize confounding factors in data generation and sharing; (3) develop a SenNet
consortium coordination plan including participation in the steering committee to improve and implement
operation protocols, joining or creating new interest groups such as “spatial omics” and “immune cell
senescence”, make commitment to work with CODCC and other TMCs for protocol and data integration and
sharing, and mange trans-network collaborations. We will adhere to Network-wide policies and procedures
established by the NIH and the SenNet Steering Committee, including data access, publication, and intellectual
property policies. We will also abide by, Memoranda of Understanding and other sharing agreements
potentially needed for data and biospecimen sharing within the Network and other related programs. The
Administrative Core will develop outreach activities to enhance data dissemination and utilization by the large
research community to improve our understanding of cellular senescence, heterogeneity and associated
environments in development, aging, and disease.